IMAGE ANALYSIS (IA) CORE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The IA CORE continues to make significant progress in developing the automation infrastructure supporting the COBRE data collection. For this progress report we will briefly describe three main areas: 1) Automated Analysis, 2) Data Fusion Tools, and 3) MEG Analysis.